Developing RNA therapeutics for rare neurodevelopmental disorders

PROJECT SUMMARY
Developing RNA therapeutics for rare neurodevelopmental disorders
Monogenic diseases caused by mutations in single genes are individually rare, but collectively common affecting
10% of the world population. Many of these diseases are disabling or even life threatening with no available
treatment. The underlying molecular mechanisms vary. Both loss of gene function and gain of toxic or dominant
negative effects can lead to pathology, and modification of gene expression could be disease modifying. DAYI
Therapeutics, Inc is a spin-out of Columbia University Medical Center that has the goal of advancing precisely
targeted RNA therapeutics for the treatment of rare monogenic diseases, especially neurological disorders
affecting the brain and behavior. Using a proprietary target discovery platform developed by our academic co-
founders, we have prioritized a list of target genes causing severe neurodevelopmental disorders with
tremendous unmet medical needs. These target genes are in general difficult to target with current approaches
but are druggable with our unique technology to identify endogenous, naturally occurring gene regulatory regions
that can be targeted by different therapeutic modalities including antisense oligonucleotides (ASOs). In this
proposal, we aim to develop the first therapeutic for a severe developmental and intellectual disability syndrome
by restoring gene expression and protein function using an ASO. The feasibility of our approach is supported
by compelling preliminary data. We propose to perform a systematic ASO drug screen to identify the most
effective ASOs as drug lead and then conduct a series of pre-clinical studies to validate their efficacy in correcting
the molecular, cellular and behavioral deficits caused by the mutation using patient-derived iPSCs, brain
organoids and mouse models. ASOs are an established therapeutic agent with the advantage of high target
specificity, clear mode of action, and accelerated timeline from drug discovery to clinical deployment. If
successful, this study will provide the critical first step to develop a novel ASO therapeutic to fulfill unmet medical
needs and potentially also serve as proof of principle for treatment of neurodevelopmental disorders caused by
mutations in a wide range of genes.

Public health relevance
PROJECT NARRATIVE Monogenic diseases, while individually rare, are collectively common and affect 10% of the global population. Many monogenic conditions are disabling and even life threatening, and most of them lack effective treatments. This proposal aims to develop the first therapeutic for a severe developmental and intellectual disability syndrome by restoring normal protein production using an antisense oligo (ASO).